Cultural and Environmental Influences on Precursors to and Early Stages of Alcohol, Nicotine, and Cannabis Use in Black and Latinx Youth

Project Summary/Abstract
By 8th grade, one in five Black youth and one in four Latinx youth has tried some form of alcohol, nicotine, or
cannabis - well after substance use related cognitions (e.g., perceived harm), which impact risk for use - have
started to form. Prevention efforts must be grounded in knowledge of how modifiable risk and protective factors
that are present prior to early adolescence may vary within (e.g., by gender) and between racial/ethnic groups
in their influences on precursors to and early substance use behaviors. Focusing on understudied cultural factors
that are especially salient for Black and Latinx youth, such as racial/ethnic discrimination and environmental
factors that are highly prevalent in Black and Latinx communities, such as religious involvement, the proposed
etiological study will integrate methodological approaches that can address both their unique and collective
influences on substance use related cognitions and use from pre- to mid-adolescence. This secondary data
analysis project is based on the Adolescent Brain Cognitive Development Study (total N=11,878), an ongoing
multi-site, population-based longitudinal study of adolescent development. Drawing on data collected at ages 9-
16 from the 10,360 participants (47.8% female) that were identified by their parents as Black (17.2%), Latinx
(23.2%), or White (59.6%), we will address three core aims. First, we will use person-centered analyses (mixture
modeling) to identify latent profiles (subgroups) of risk and protection based on cultural and environmental factors
(e.g., acculturation, parental support) and substance use related cognitions (perceived harm, expectancies,
intentions to use) that predate and evolve as a function of substance use. Second, to gain a more nuanced
perspective on the early course of substance use, we will apply mixture modeling, survival analysis, and a novel
modeling approach integrating the two, to identify possible distinctions between and among Black, Latinx, and
White youth in timing of progression through early stages (experimentation, initiation, and - as the cohort ages -
regular use), circumstances of use (e.g., how obtained), as well as type/method of use (e.g., beer vs. hard liquor,
cannabis vaping vs. edibles). Third, building on this foundation, we will identify cultural and environmental
influences that modify the course of substance use in Black and Latinx youth, focusing on common prevention
targets, such as ethnic identity and parental monitoring. In addition to extending the models (e.g., incorporating
moderators) derived for Aims 1 and 2, we will apply propensity score matching, integrating geocoded
neighborhood data, to parse out the unique influence of risk factors, such as trauma, from the conditions that
elevate risk for experiencing them. Identifying similarities and distinctions across and considering differences
within (e.g., by gender) racial/ethnic groups in the impact of cultural and environmental influences on precursors
to and early stages of substance use will contribute to refining etiological models of substance involvement in
Black and Latinx youth that can inform prevention and ultimately reduce substance use related health disparities.

Public health relevance
Project Narrative Reducing harms associated with early and problem use of alcohol, nicotine, and cannabis among Black and Latinx youth requires insight into the family and community level cultural and environmental factors most salient to substance use risk in Black and Latinx girls and boys from the pre- to mid-adolescent years. The proposed secondary data analysis project focuses on cultural and environmental factors of particular relevance to members of racial/ethnic minority groups, such as racial/ethnic discrimination and ethnic identity, as well as those more prevalent in Black and Latinx than White youth (e.g., neighborhood disadvantage, religious involvement) to characterize pathways of substance use - from cognitions that precede first use to early onset regular use - from ages 9 to 16. Findings will lay the groundwork for cultural tailoring of substance use prevention strategies for Black and Latinx youth toward the broader goal of reducing substance use related health disparities.